Cell wall carbohydrate recycling in Mycobacterium tuberculosis

Project Summary
A typical course of antibiotics for tuberculosis (TB) lasts for six months. Subpopulations of non/slow-replicating
Mycobacterium tuberculosis have long been hypothesized to be tolerant to antibiotics and contribute to lengthy
treatment. Pathways that are active in quiescent M. tuberculosis are high value targets for drug discovery,
particularly extracellular components that are freely accessible to small molecules. Cell envelope recycling is
an example of a vulnerable pathway in stressed, non/slow-replicating M. tuberculosis. Recycling of the
trehalose component of the outer mycomembrane, which occurs in several in vitro models of stress, promotes
M. tuberculosis survival in macrophages and in vivo as well as antibiotic tolerance. While the mycomembrane
is a distinctive attribute of the Mycobacteriales cell envelope, these organisms also have a more-conserved
peptidoglycan cell wall. Very little is known about cell wall turnover and reuse in the Mycobacteriales. In other
bacteria, cell wall recycling genes usually do not contribute to fitness in standard laboratory conditions but can
support survival in stationary phase and tolerance to certain cell wall-acting antibiotics. Using bioorthogonal
metabolic labeling, the investigators serendipitously discovered that M. tuberculosis, M. smegmatis, and
Corynebacterium glutamicum recycle the peptidoglycan sugar N-acetylmuramic acid in a manner that is not
explained by their known repertoire of cell wall recycling genes. The central hypothesis of this application is
that Mycobacteriales MurNAc recycling occurs via a novel mechanism and promotes survival in stressed,
non/slow-replicating M. tuberculosis. To test, the investigators will identify and characterize MurNAc recycling
genes in M. tuberculosis and determine the phylogenetic distribution of the pathway within and outside of the
Mycobacteriales. Successful execution of the proposed work 1) will reveal fundamental mechanistic insight into
cell envelope homeostasis not previously defined in standard model organisms and 2) uncover new
vulnerabilities in non/slow-replicating M. tuberculosis, including inner- and mycomembrane transporters with
good accessibility to small molecules. The results will also form the basis for future investigation of MurNAc
recycling in vivo and as a potential antibiotic target.

Public health relevance
Project Narrative The ability of bacteria to recycle components of their cell envelopes can help them to survive inside of a host and in the face of antibiotic-induced envelope damage. We will examine how the important human pathogen Mycobacterium tuberculosis recycles one of its cell wall sugars, a pathway that our preliminary data suggest is distinct from known cell wall recycling pathways. Targeting factors that enable M. tuberculosis to survive stress has the potential to sensitize the bacterium to both the immune system and to therapeutics.